RFA-GH-20-002, Malaria Operations Research to Improve Malaria Control and Reduce Morbidity and Mortality in Western Kenya

Project summary
This application is for the fourth, 5-year CoAG between CDC’s Malaria Branch and the Liverpool School of Tropical
Medicine (LSTM). Activities take place in western Kenya under the umbrella of the long-term collaboration between
the Kenya Medical Research Institute (KEMRI), CDC, and LSTM and benefit from LSTM’s existing infrastructure in
Kenya. The research strategy follows the 5 objectives of the NOFO. The first objective involves the expansion in
2020/21 of the epidemiological (1.1) and entomological surveillance (1.2) platform to track progress towards malaria
transmission reduction targets following the introduction of population-wide interventions in 2021/22. To maintain
low transmission status, this requires a shift from the existing periodic, district-level surveillance to systems where
surveillance itself becomes an intervention and can detect individual geo-located cases near real-time for rapid
notification and foci investigation. We will support the Kenyan Ministry of Health (MoH) with their goal to digitise
the data collected on their paper-based health registers using software that makes them scannable (1.1.5). This will
include registers that capture case-burden data used in out-patient departments (1.1.6) and by community health
workers as part of integrated community case management (ICCM) (1.1.7), and antenatal clinic registers that
capture malaria infection prevalence during first antenatal clinic visits. This is a novel method to track the
asymptomatic parasite reservoir in populations (1.1.8). Combined, this allows, for the first time, sustainable, daily,
near real-time surveillance to track progress towards malaria transmission reduction targets. We will also conduct
continuous malaria indicator household surveys (cMIS) to track malaria prevalence and intervention coverage (1.1.9)
and entomological monitoring (1.2), both using adaptive sampling frameworks that can respond to challenges
related to rapid changes in malaria transmission. As part of the second objective, we will implement population-wide
interventions targeting malaria transmission, starting in 2021/22. The optimal combination of novel or improved
interventions will be developed in close collaboration with CDC in 2020/21. This is likely to include enhanced case-
management using digitally supported quality improvement approaches of ICCM, enhanced vector control with
larval source management and insecticide-treated piperonyl butoxide (PBO) nets, and mass drug administration with
dihydroartemisinin-piperaquine and ivermectin targeting the asymptomatic parasite reservoir (2.1). The third
objective involves assessing the safety effectiveness of currently deployed antimalarials for the prevention (3.2.1)
and treatment (3.2 and 3.3) of malaria in the context of increasing antimalarial drug resistance. We will liaise with
CDC’s laboratories in Atlanta for the molecular monitoring of drug resistance. The fourth objective aims to maximise
the public health impact by supporting the creation of a knowledge centre at the KEMRI’s CGHR for evidence
synthesis and information exchange to enhance the translation of global malaria control policies (4). Objective 5
involves the strengthening of research capacity of the partners in Kenya by the provision of internships (5.1) and
MSc, PhD and post-doctoral studentships and research leadership mentoring (5.1).

Public health relevance
PROJECT NARRATIVE This CoAg supports a collaboration between the Kenya Medical Research Institute (KEMRI), the US CDC and the Liverpool School of Tropical Medicine (LSTM) to support the Kenyan Ministry of Health to achieve major reductions in the malaria burden in areas with intense year-round transmission in western Kenya by 2025. The partnership will support the expansion of the malaria surveillance infrastructure to track the progress towards malaria transmission targets, evaluate different combinations of area-wide interventions targeting the malaria vector and asymptomatic parasite reservoir to reduce malaria transmission and strengthen case management. These activities will provide pivotal critical scientific knowledge to inform and guide malaria program implementation and reduce malaria-associated morbidity and mortality through the identification and scale-up and continued evaluation of evidence-based intervention strategies.